Human mast cells as a platform for new cancer immunotherapy strategies

ABSTRACT
The role of human tissue mast cells (MC) in the pathology of many cancers is not known. Correlative studies in
humans have found high MC numbers in the tumor microenvironment have pro- and anti-tumor effects and
contrasting patient outcomes depending on the cancer types. We discovered that human MC, are activated by,
and promote killing of, cancer cells in vitro and in vivo, infiltrate solid cell tumor masses, bind to tumors in vivo,
can be obtained in quantities necessary for patient infusion, cryopreserved without loss of function, and display
no overt toxic effects when injected intravenously into mice with engrafted human tumors. To develop this novel,
cell-based cancer immunotherapy we will utilize FDA approved humanized IgE (which bind MC FcεRI with
extremely high affinity) to target MC to cancer cells. This new approach is premised on efficient, autologous
production of MC, tumor targeting, and effective tumor specific killing. This strategy has not been feasible
heretofore as these cells reside in tissue and cannot be obtained for autologous use. Our overall hypothesis is
tumor targeted MC will bind to cancer cells in vitro and in vivo after intratumoral or intravenous administration
and elicit significant anti-tumor activity. Here we will determine the in vitro and in vivo activity of human MC
against several cancer types. These studies could lead to new adoptive cell therapies for diverse cancers ranging
from lymphoma to breast cancer.

Public health relevance
PROJECT NARRATIVE The goal of this project is to use, for the first time, autologous mast cells armed with tumor targeting IgE antibodies as a novel “Trojan horse” therapy against diverse cancer types including lymphoma and breast cancer. Based on evidence already obtained demonstrating in vitro and in vivo efficacy, this translational study will ultimately lead to further safety and efficacy studies required to move this novel approach into the clinic.